Elucidating the role of Cullin 3 in the heart

PROJECT SUMMARY
Cardiomyocyte (CM) mitochondria play a crucial role in energy production and other essential cellular processes.
Disruptions in mitochondrial homeostasis contribute to cardiomyopathies and heart failure, which remain
significant global health challenges. Therefore, it is vital to identify novel regulators of mitochondrial homeostasis
in the heart to reduce cardiac dysfunction-related mortality. Proper control of mitochondrial biogenesis and
turnover is essential for maintaining a healthy mitochondrial population in CMs. Recent research has highlighted
the importance of mitochondrial DNA transcription in mitochondrial biogenesis, as well as the role of ubiquitin
(Ub) ligase PARKIN in mitophagy. However, there are significant knowledge gaps regarding the upstream
signaling involved in mitochondrial DNA transcription and other mitochondrial Ub ligases crucial for mitophagy
in CMs. Cullin 3-RING Ub ligase (CRL3) belongs to the multi-subunit Cullin-RING Ub ligases (CRLs) family. In
the CRL3 complex, Cullin 3 serves as a scaffold for interacting with the RING-box protein RBX1 and one of the
substrate receptors. The assembly of CRL3 requires the conjugation of Cullin 3 by the Ub-like protein NEDD8
(neddylation). Known as a cytosolic Ub ligase, CRL3 controls the degradation of numerous proteins and
participates in multiple pathophysiological processes such as organismal development, tumor growth, vascular
integrity, and renal sodium transport. Moreover, mutations in Cullin 3 were shown to cause familial hyperkalemic
hypertension, autism spectrum disorders, and epilepsy. Despite the increasingly recognized importance of CRL3
in health and disease, its role in mitochondria and the heart remains largely unknown. In silico analyses have
revealed an intricate interaction between CRLs and mitochondrial homeostasis. Disturbances in CRLs adversely
affect mitochondrial integrity and function in CMs, and depletion of Cullin 3 inhibits mitochondrial turnover and
respiration capacity, suggesting a potential role for CRL3 in maintaining mitochondrial homeostasis. Notably,
neddylation of Cullin 3 is downregulated during cardiac development but upregulated in human failing hearts and
mouse hearts undergoing pathological remodeling. Hence, the goal of this project is to investigate the
pathophysiological significance of Cullin 3 in the heart and to elucidate the molecular mechanisms by which
Cullin 3 regulates mitochondrial homeostasis using a series of newly generated, genetically engineered mouse
models and adenovirus-associated viruses. Three interconnected yet independent aims are proposed: Aim 1 will
assess the importance of neddylated Cullin 3 in cardiac maturation and mitochondrial biogenesis, Aim 2 will
establish the functional significance of Cullin 3 in mitochondrial turnover in the adult heart, and Aim 3 will
investigate the impact of Cullin 3 mutations and deficiency on cardiac remodeling while exploring the potential
of targeting Cullin 3 to prevent stress-induced cardiac damage. Successful completion of these experiments will
expand and deepen our understanding of how mitochondrial homeostasis is maintained in the developing,
homeostatic, and remodeling heart.

Public health relevance
PROJECT NARRATIVE Mitochondria serve as the powerhouses to sustain their continuous beating of heart muscle cells, and their dysfunction has been linked to various cardiac and systemic disorders. This investigation aims to elucidate the significance of Cullin 3-RING ubiquitin ligase in monitoring and maintaining mitochondrial health under normal and stressed conditions in the heart. Completion of the proposed studies not only offers potential therapeutic targets for heart failure but also provides valuable fundamental insights into biological processes with broad applicability.